Effect of post-acute care pay for performance in skilled nursing facilities on outcomes and disparities

Project summary
Post-acute care (PAC) is increasingly common and costly. One in five Medicare beneficiaries receives care
after hospitalization in a skilled nursing facility at a cost of more than $28 billion annually. Unfortunately, more
than 1 in 4 Medicare beneficiaries are readmitted to the hospital within 30 days, and these readmissions are
associated with increased mortality. The Skilled Nursing Facility Value-Based Purchasing program (SNF VBP)
ties Medicare reimbursements to SNF to their 30-day all-cause hospital readmission rates. Determining the
effect of SNF VBP on patient outcomes is crucial for patients, health systems, and policymakers, and will
inform the development and implementation of similar programs in other post-acute care settings. Evaluating
potential unintended consequences of this policy is especially important because SNFs face significant
financial pressure, and SNFs that care for large proportions of patients who are especially vulnerable to
adverse outcomes (e.g. frail, cognitively impaired, poor, or racial and ethnic minority populations) are most
likely to be penalized under the program, potentially leading to increased disparities. The COVID-19 pandemic
may have magnified the effects of SNF VBP, acting as a second “stress” on SNFs already stressed by SNF
VBP. There is an urgent need to determine the effect of SNF VBP on patient outcomes and on disparities,
especially given the magnifying effect of COVID-19. Our long-term goal is to drive the delivery of high-value
care for all older adults leaving the hospital. SNF VBP is among the first pay-for-performance programs in post-
acute care settings. In order to improve the development and success of these policies, it is crucial to
understand how their design and implementation influences outcomes. Our central hypothesis, based on
preliminary data, is that SNF VBP achieves its intended effects at SNFs that were already high-performing, but
has unintended and negative effects at low-performing SNFs. Our specific aims are to: 1) Determine the
impact of SNF VBP on intended outcomes prior to the COVID-19 pandemic; 2) Determine the effect of SNF
VBP on disparities in outcomes in vulnerable populations; 3) Determine how financial penalties from SNF VBP
impacted COVID-19 readiness and outcomes; and 4) Assess key aspects of organizational context among
SNFs that improved performance in SNF VBP and explore how this impacted their response to COVID-19.
Accomplishing these aims will improve the design of future VBP initiatives, and lead to higher-value care for
the growing number of vulnerable older adults receiving SNF care.

Public health relevance
Project narrative/public health relevance statement This project will examine the effects of the Skilled Nursing Facility Value-Based Purchasing program on outcomes for older adults leaving the hospital and entering skilled nursing facilities for post-acute care. This is important because one in five Medicare beneficiaries currently receives post-acute care in a skilled nursing facility, and this care is expensive and frequently associated with adverse outcomes. Understanding how this program achieves intended results, and what unintended consequences may come from the program particularly given the effects of the COVID-19 pandemic, will help shape payment programs intended to improve outcomes in post-acute care.